ASPH Targeted Therapy for Chondrosarcoma

PROJECT SUMMARY/ABSTRACT
The long-term objective of this application is to improve the survival and quality of life for patients with
chondrosarcoma, a primary malignant bone tumor desperately in need of more effective treatments. The five-
year survival for chondrosarcoma, the most common bone sarcoma in adults, is an abysmal 10-25%, with most
patients succumbing to pulmonary metastases. Conventional cytotoxic chemotherapy has no effect on
chondrosarcoma, so the current standard of care is surgical resection. There has been no improvement in the
cure rate for chondrosarcoma in the last several decades. The goal of this proposal is to systematically evaluate
promising new treatment strategies that target aspartate β-hydroxylase (ASPH), a transmembrane protein that
is normally expressed during embryonic development, but not after birth. We have found that ASPH is re-
expressed in chondrosarcoma. In some carcinomas, ASPH signals through the Notch pathway to influence the
expression of matrix metalloproteinases (MMPs) and vascular endothelial growth factor (VEGF), which support
cell proliferation, invasion, and metastasis. We have data suggesting that ASPH functions similarly in
chondrosarcoma. ASPH is highly expressed in >90% of chondrosarcomas, as are activated Notch and multiple
MMPs, and high ASPH expression correlates positively with tumor grade and poor long-term survival. Inhibition
of Notch is a long sought after but, as of yet, unachieved goal in cancer treatment. The work in this proposal will
advance ASPH as a potential therapeutic target by determining the relationship between ASPH and Notch in
chondrosarcoma. First, ASPH levels in human chondrosarcoma cell lines will be modulated using CRISPR-Cas9
gene editing, followed by treatment with a proven small molecule inhibitor (SMI) of ASPH. Changes in
proliferation, invasion, apoptosis, and Notch signaling will be used as mechanistic readouts of ASPH signaling
in vitro. Notch signaling will be manipulated in these ASPH-modulated cell lines with gain and loss of function
approaches to evaluate the role of Notch in ASPH signaling (Aim 1). Second, the role of ASPH and Notch in
chemotherapy resistance will be evaluated in human chondrosarcoma cell lines, and the ability of the SMI and
an ASPH-targeted antibody-drug conjugate (ADC) to enhance doxorubicin efficacy will be tested (Aim 2). Finally,
three different approaches to targeting ASPH will be evaluated in vivo using mouse chondrosarcoma models:
SMI inhibition of ASPH, SMI + doxorubicin, and an antibody-drug conjugate targeting ASPH linked to emtansine
(Aim 3). The completion of these aims will provide important insight into the biology of chondrosarcoma and
determine whether the therapeutic targeting of ASPH has potential as an effective strategy for the treatment of
these malignancies. The results may also have wider impact and be applicable to patients with other types of
bone and soft tissue sarcomas.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because it addresses cancer drug resistance, a National Cancer Institute (NCI) scientific priority. Malignant cartilage bone cancers have a poor prognosis due to lack of effective drug treatments. The goal of this proposal is to systematically evaluate promising new treatments that target aspartate β-hydroxylase (ASPH), a cell surface protein that influences the growth, spread, and resistance of cancer cells, with the ultimate goal of improving patient survival and quality of life.